Mechanisms of early tracheal specification and morphogenesis

Project summary
Congenital anomalies of the trachea, including tracheoesophageal fistula (TEF), are common, affecting around
1:3000 live births. TEF is defined as the inappropriate maintenance of a connection between the trachea and
esophagus, and arises as a result of a failure of the complete separation of these structures from their common
origin, the foregut endoderm tube. Normally, induction of respiratory identity in the ventral foregut endoderm
and initiation of lung bud outgrowth is followed immediately by a morphogenetic separation of the ventral
trachea from the dorsal esophagus. Despite the common occurrence of TEF, our understanding of the
pathways that control this developmental process is incomplete, and almost no knowledge exists regarding the
molecular effectors of separation. Further, the cell biological mechanisms by which the trachea separates from
the esophagus are currently not known. Our proposal incorporates genome-wide approaches including RNA
sequencing and chromatin immunoprecipitation sequencing, and integrates them with mouse genetics and
imaging approaches to better understand how control of tracheal cell fate specification is coupled to the cell
biological drivers of separation. This work will provide new insights into how early tracheal development is
regulated, improve our understanding of TEF, and provide a resource for future regenerative and tissue
engineering approaches that require a detailed understanding of early tracheal gene regulatory networks.

Public health relevance
Project narrative This proposal focuses on the early development of the trachea particularly as related to a congenital condition wherein the trachea fails to separate properly from the esophagus during development, resulting in a connection between the two, known as tracheoesophageal fistula. This proposal seeks to better understand how tracheal cell fate identity is coupled to the physical separation of the trachea from the esophagus. This work will provide insight into the normal and disease mechanisms of early tracheal development and provide new resources for future regenerative biology applications.